The novel role of FGF21 in mediating sex-dependent responses to dietary macronutrients

Because sex differences exist in almost all aspects of the metabolic syndrome, treatments developed
using only male subjects elicit a disproportionate risk for adverse, off-target, or simply ineffective outcomes
among female patients. Yet the vast majority of pre-clinical biomedical research focuses only on males. Fibro-
blast growth factor 21 (FGF21), a polypeptide hormone produced by the liver in response to nutritional stress,
is a promising target for treatment of metabolic disease. In males, administration at pharmacologic doses im-
proves glucose tolerance, and reduces body weight and body fat by increasing sympathetic outflow to adipose
tissue, increasing thermogenesis. Consequently, several major companies are developing FGF21-based com-
pounds for clinical use. Yet surprisingly little is known about the metabolic actions of FGF21 in females. Our
recently published and preliminary data strongly support that FGF21 functions as a key mechanism facilitating
the sexually dimorphic metabolic response to dietary protein ‘dilution’—a novel nutritional intervention eliciting
weight loss and improved glucose and lipid metabolism in male mice, rats and humans. In this project, we plan
to address the next critical step, by identifying specific neuroendocrine and cell-autonomous mechanisms by
which FGF21 elicits divergent metabolic responses in males and females. The overarching hypothesis in this
proposal is that, in the presence of estrogen receptor-beta, FGF21 signaling in the hypothalamus increases the
sympathetic drive to adipose tissue in males but not females, and FGF21 signaling in the adipocyte inhibits the
catabolic response to adrenergic stimulation in females but not males. We will test hypothesis using pharmaco-
logic, genetic and nutritional manipulations of FGF21 signaling in the brain (Aim 1) and adipose tissue (Aim 2)
of male and female mice, together with indirect calorimetry, and isotopic tracer-assisted measurements of lipid
turnover. These experiments are expected to delineate neuroendocrine and molecular mechanisms contrib-
uting to the sexually dimorphic regulation of fat mass, thereby facilitating the appropriate and targeted delivery
of nutritional and pharmacological interventions in obesity and metabolic disease. In light of the considerable
interest in FGF21 itself as a therapeutic target, we are surprised to note that almost nothing is known about its
metabolic effects in female subjects. Therefore, this work is not only physiologically important, but it will also
provide new insights in the clinical application of FGF21-based therapeutics in both men and women.

Public health relevance
Men and women have very different responses to changes in diet, and the causes of these metabolic differences could have important impacts on how they respond to medication for weight loss or diabetes control. This is relevant to public health and to the NIH mission to conduct research on nutrition, obesity, aging, diabetes, and other metabolic diseases